Mechanisms of peptidoglycan-induced modulation of metabolic and inflammatory responses to bacteria

ABSTRACT
Immune surveillance by phagocytic cells plays a vital role in controlling infections by internalize bacteria and
kill them by a process of enzymatic degradation. Degradation also releases bacterial molecules that activate
innate immune receptors and antigens for presentation to the adaptive immune system ultimately
orchestrating the overall immune response to a microbe. The cell wall of gram-positive bacteria, like
Staphylococcus aureus, is predominantly composed peptidoglycan, an amino acid-crosslinked sugar
polymer. We recently demonstrated that the monomeric sugar, n-acetylglucosamine, released during
peptidoglycan degradation, is inflammatory. N-acetylglucosamine interacts with the glycolytic enzyme
hexokinase, inhibiting its function. As a consequence, hexokinase’s interaction with the mitochondrial outer
membrane is disrupted and this dissociation initiates a signaling cascade responsible for assembly of the
multi-protein NLRP3 inflammasome complex necessary for activation of the protease caspase-1. Caspase-
1 is responsible for the cleavage and activation of several key inflammatory cytokines, including IL-1b and
IL-18, important for inflammatory cell recruitment and activation. Our results suggest that phagocytic cells
have adapted their normal glycolytic regulation to sense abnormally high levels of a bacterial sugar as
danger. To evade immune surveillance, bacteria modify their peptidoglycan layer to resist degradation by
phagocytic cells and limiting the availability of innate inflammatory signals, including n-acetylglucosamine.
The amount of n-acetylglucosamine impacting hexokinase function and glycolysis will depend on transport
across the phagosomal membrane into the cytosol. Preliminary evidence suggests that the amount of IL-
1b produced by phagocytic cells, specifically in response to peptidoglycan, is dependent on the function of
the GLUT family of sugar transports. In addition, we have generated a mouse model deficient for one of the
three hexokinases expressed by phagocytic cells and observed differential impacts on glycolysis and
inflammatory responses. This proposal aims to define the roles of the three hexokinases expressed by
phagocytic cell in the inflammatory response to gram-positive bacteria peptidoglycan, as well characterize
the transport and impact of peptidoglycan-derived n-acetylglucosamine on the metabolism and
inflammatory responses of phagocytic cells. We hypothesize that the overall degree of inflammation induced
by gram-positive bacteria is impacted by the amount and availability of n-acetylglucosamine generating
during bacterial peptidoglycan degradation due in part to n-acetylglucosamine’s inhibition of glycolytic
metabolism.

Public health relevance
NARRATIVE The earliest cells involved in the immune response to a bacterial infection are the phagocytic cells responsible for internalize, kill bacteria and generate inflammatory signals that coordinate the subsequent immune responses. Recently, we determined that phagocytic cells respond to a sugar that is abundant in the bacterial cell wall and is released when bacteria are degraded and killed. This proposal aims to determine how this bacterial-derived sugar alters the metabolism of phagocytic immune cells and controls the level of inflammation that develops during a bacterial infection in order to better design therapeutics to treat bacterial infections.